Characterization of iGL-VRC01 Memory B cell Responses in Mice

PROJECT SUMMARY
The behavior of B cell memory in mice and humans is an active area of research with implications for
traditional vaccine design and for the development of our engineered B cell vaccine (parent award). There
is data in mice supporting the idea that memory B cells have a very limited ability to re-enter germinal
centers. Alternatively, it has been shown that diﬀerent memory phenotypes exist with some showing a
preference for germinal center re-entry. We hypothesize that memory behavior, similar to naive cell
behavior, may also depend on immunogen aﬃinity, valency, and availability of T cell help. We will explore
these ideas by generating various memory phenotypes using in vitro B cell activation and adoptive transfer
to increase the frequency of antigen-speciﬁc memory in the B6 mouse model (which is normally very low).
We will then vaccinate using antigens with deﬁned aﬃinities and valency’s to see if these factors impact
memory cell developmental fates. We would also like to immunize memory at diﬀerent times to see if
changing memory B cell surface markers are associated with altered cell behaviors in response to
vaccination.

Public health relevance
PROJECT NARRATIVE iGL-VRC01 B cells from KI mice will be activated in vitro and adoptively transferred into WT animals to generate higher than normal frequencies of antigen speciﬁc memory B cells with different important memory phenotypes. These cells will be vaccinated with high to low afﬁnity and valency immunogens and the responses generated from memory B cells will be assessed. This study will complement previous work with naive iGL-VRC01 cells and their responses to similar panels of immunogens.